Neuronal regulation of adult taste stem cells

PROJECT SUMMARY
This proposed research will elucidate the molecular basis of neuronal regulation of adult taste stem cells. Taste
organs degenerate in the absence of neuronal input, a phenomenon described more than a century ago, but
the cellular and molecular mechanisms underlying this are not well defined. We propose to use a combined in
vivo and in vitro approach to determine if R-spondin-2 (Rspo2), via interaction of its taste stem cell-expressed
receptors Lgr5/Lgr6 and/or Znrf3/Rnf43, is the gustatory-neuron-produced factor that maintains taste bud
integrity.
In Aim 1, we will determine if Rspo2 is required for taste bud maintenance. Using a loss-of-function approach,
conditional ablation of Rspo2 from gustatory neurons that innervate taste tissue will help determine whether
gustatory neuron-produced Rspo2 is necessary to maintain taste bud integrity. Conversely, in a gustatory
nerve transection model that leads to taste tissue denervation, we will determine if systemically supplied
recombinant Rspo2 via adenovirus and purified protein is sufficient for taste cell generation and taste bud
regeneration in the absence of gustatory innervation. The loss-of-function and gain-of-function will establish the
role of Rspo2 in neuronal regulation of taste tissue maintenance. In Aim 2, we will determine if Rspo2 interacts
with its taste stem cell-expressed receptors Lgr5/Lgr6 and/or Znrf3/Rnf43 to regulate taste stem cell activity.
We will use genetic approaches, Rspo2 mutants that selectively bind to Lgr5/Lgr6 or Znrf3/Rnf43, taste
organoid culture, and gustatory nerve transection to determine how Rspo2 acts.
Cancer patients who receive chemotherapy or radiotherapy often experience taste disturbance. The distortion
or loss of taste can lead to appetite loss and malnutrition. The mechanisms for drug-induced taste disturbance
are not clear, but dysregulation of adult taste stem cell activity could be the culprit. Accomplishing the aims
proposed here will be significant steps toward developing strategies for mitigating taste disturbances
experienced by individuals who suffer from taste loss or taste distortion.

Public health relevance
PROJECT NARRATIVE Taste bud integrity requires innervation from gustatory neurons, but how neurons regulate taste bud homeostasis is not well established. We will use genetically engineered mice, a gustatory nerve transection model, adenovirus encoding recombinant proteins, and a novel three-dimensional taste organoid culture model to determine the role of the gustatory neuron-produced factor R-spondin-2 in regulating adult taste stem cell activity. The results from this project may help develop novel treatment strategies for individuals who experience taste impairments such as cancer patients receiving chemotherapy or elderly with reduced taste sensibility.